FLUORESCENCE SATURATION IN 3 LEVEL SYSTEMS IN FLUORESCENCE CORRELATION SPECT

We have been evaluating the data we have collected for our action spectrum of DNA synthesis inhibition to determine the excitation order, n, using the general dose-response equation, , where S is the normalized survival and the dose, D, is defined as Int. (The irradiance, I, is in photons/s((m2, and n is the number of photons required for a single excitation event, or the excitation order.) Preliminary analysis suggests that the observed damage is arising from different absorbing species at different wavelengths -- at 700 nm damage appears to be from one-photon events and at 740 nm it appears to be from two-photon events. Further studies are underway to confirm this observation.